Exploiting dynamic in vivo interactions of peptide amphiphiles with lipid-containing biomolecules to develop a universal drug delivery platform

Abstract.
Delivering therapeutic drugs specifically to target tissues with minimized off-target accumulation can improve the
efficacy and safety of therapies. With this overall motivation, various delivery platforms have been developed in
recent years for targeted drug delivery, including antibody-drug conjugates (ADCs) and nanomedicines. These
drug delivery platforms typically target an antigen to deliver toxins into diseased cells. However, targeting a
specific antigen brings several important limitations such as antigen expression in healthy tissues often causing
a narrow therapeutic window, inter- and intra-patient heterogeneity in antigen expression yielding highly variable
response only in a subpopulation of patients, and development resistance against therapy due to the post
translational modifications or loss of antigen expression. To address these issues with targeted therapies, in this
proposal, we will utilize a novel peptide amphiphile (PA) platform that our lab recently developed. These PAs
dynamically interact with two types of endogenous lipid-containing biomolecules, lipoproteins and lipid rafts, and
exploit them to target a broad range of solid tumors. In the preliminary experiments, we found that our PAs
strongly accumulated in ~15 xenografted, syngeneic, and transgenic tumor models in mice and rats, including
tumors with sizes <1 mm. We have also shown that our PAs can deliver different small molecule drugs in cells,
enabling improved anti-tumor efficacy in mouse models with reduced side effects compared to free drugs.
Building upon these results, our goal in this proposal is to develop a platform that can universally deliver a broad
range of drugs to human diseases without targeting a specific antigen. Another major goal of this proposal is to
perform in-depth mechanistic studies to better understand the biodistribution of PAs and their trafficking in cancer
cells. To achieve these goals, we will rationally design a library of PAs using different saturated and unsaturated
lipid modifications and evaluate their interactions with plasma components, cell membranes, and subcellular
components using in vitro experiments and molecular dynamics simulations in the first Aim. The second Aim will
evaluate the effects of PA structure on their biodistribution in wild-type and tumor-bearing mice. We will also use
various genetically engineered mouse models to understand how aberrant lipoprotein metabolism, such as high
cholesterol and cholesterol medicines, affects the biodistribution of PAs as they are trafficked in vivo on lipid-
containing biomolecules. In the final Aim, we will evaluate this platform to deliver a broad range of drugs with
varying hydrophobicities and mechanisms of action in mouse models. At the conclusion of this project, we will
learn more about the universal cancer-targeting mechanism of our PA platform. In addition, we will optimize its
structure further for the precise delivery of various drugs. If successful, our technology will be available to deliver
a broad range of drugs and contrast agents to detect and treat almost any type of cancer and potentially other
diseases associated with increased lipid metabolism, such as cardiovascular diseases and inflammation.

Public health relevance
Project narrative. This project will evaluate novel peptide amphiphiles that can dynamically assemble with lipid-containing biomolecules in vivo and exploit them to accumulate specifically in a broad range of solid tumors. At the conclusion of this project, we expect to gain critical insights into the mechanisms that peptide amphiphiles utilize to specifically deliver cargo to cancer. This information will allow us to further refine the structure of peptide amphiphiles for the effective delivery of a broad range of medicine to cancer and potentially other diseases.